Functional Redundancy of Human Microbiome and its Implication in Fecal Microbiota Transplantation

Project Summary
Commensal microorganisms play critical roles in human physiology and diseases. Despite rapidly
expanding knowledge of the composition of the human gut microbiota, our understanding of the
ecological principles that govern the assembly and resilience of the highly complex and dynamic
ecosystem of the gut microbiota is rudimentary. This knowledge gap becomes more problematic as new
approaches to modify the microbiota, such as fecal microbiota transplantation (FMT), are being
developed as therapeutic interventions. The overall objective of the proposed studies is to construct an
ecological framework to understand the efficacy of FMT in treating recurrent C. difficile infection (rCDI) at
the systems level. The central hypothesis is that the functional redundancy of the recipient’s pre-­FMT
microbiota can be used to predict the extent of donor microbiota engraftment and predict the efficacy of
FMT. As a classical concept in ecology, functional redundancy (FR) means that phylogenetically
unrelated species perform similar functions in ecosystems so that they can be interchanged with little
impact on the overall ecosystem functioning. The rationale for the proposed research is that
understanding the efficacy of FMT in treating rCDI has the potential to translate into better understanding
of its efficacy in treating a variety of other diseases associated with disrupted microbiomes. Guided by
strong preliminary data, the central hypothesis will be tested by pursuing three specific aims: 1) Develop
a network-­based method to quantify the within-­sample FR of human microbiome samples. The
applicant’s preliminary results suggest that the FR of a microbiome sample can be calculated from its
taxonomic profile and a reference genomic content network. 2) Develop an ecological framework to study
the relationship between the FR of a microbial community and its resistance to new species. The working
hypothesis is that the higher the within-­sample FR of a microbial community, the more resistant it is
against species addition, e.g., through FMT. Both ecological modeling/simulations and real data analysis
will be performed to verify this hypothesis. 3) Clinical study to test that FMT has a lower efficacy in
treating rCDI patients with higher FR in their pre-­FMT microbiota. Stool samples from the recipients and
their respective donors will be collected for metagenomic whole genome shotgun sequencing.
Subsequently, the relationships among the FR of the recipients’ pre-­FMT microbiota, the engraftment of
donor-­specific species in the recipients’ post-­FMT microbiota, and the FMT efficacy will be quantitatively
analyzed. The approach is innovative because it shifts focus from specific taxa or functions to a systems
level understanding of the human gut microbiome using network and ecological approaches. The
proposed research is significant because it will improve our understanding on the ecological principles of
FMT for rCDI as well for other conditions associated with disrupted microbiomes.

Public health relevance
Project Narrative The proposed research is relevant to public health because revealing the intricate relationship between the functional redundancy of microbial communities and the efficacy of fecal microbiota transplantation are ultimately expected to increase understanding of the efficacy of general microbiome- based therapies in treating a wide range of diseases associated with disrupted microbiomes. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge about the nature and behavior of living systems and the application of that knowledge to enhance health and reduce illness.